Cancer Epidemiology, Prevention and Control

PROJECT SUMMARY
The Cancer Epidemiology, Prevention and Control Program (CEPC) is an interdisciplinary program with a research portfolio spanning the cancer control continuum. The program’s ultimate purpose is to reduce the population burden of cancer through four research aims on cancer etiology, early detection, prevention, and survivorship; this is aligned with the Consortium’s strategic plan. CEPC has cancer health disparity-focused research in each of the areas represented by the four aims. Research is conducted in both general and targeted populations, including those experiencing cancer health disparities. CEPC works closely with Community Outreach and Engagement to ensure bidirectional partnerships with community stakeholders and to guide research relevant to the Consortium catchment area and beyond. Interwoven with the research goals is an active program of cancer research and career training. CEPC is led by Program Co-Leaders Drs. Marian Neuhouser and Eric Chow with Drs. Margaret “Peggy” Hannon and Scott Ramsey as associate program leaders. CEPC has 71 members (including 13 new this cycle) from all three Consortium institutions, representing many scientific disciplines including epidemiology, health services, health economics, health outcomes, behavioral sciences, medical oncology, nutrition, psychology, and genetics. CEPC members have $28M in research funding, of which $17.4M (62%) is peer-reviewed, including $9.7M from NCI. In addition to high-impact investigator-initiated research, CEPC provides leadership for major national infrastructure efforts including the Women’s Health Initiative and a CDC Health Promotion and Disease Prevention Center as well as the Hutchinson Institute for Cancer Outcomes Research, each enabling the conduct of cancer control research across the catchment area and nation. CEPC program members published 1,753 papers this cycle, of which 23% reflected intraprogrammatic collaborations, 28% reflected interprogrammatic collaborations and 19% had impact factor >10. CEPC research is highly collaborative with 23 multi-PI grants during 2019-2023, including both internal and external collaborations with investigators at other Comprehensive Cancer Centers. The Consortium supports CEPC with a strategic plan that provides an overarching and unifying scientific framework, administrative and logistical support for CEPC meetings and retreats, pilot and new investigator awards, career development and professional training and outstanding shared resources. CEPC has a long and productive history of making landmark contributions across the cancer control continuum that have changed practice, paradigms, and policy.